Adaptation and Refinement of a Clinically Applicable Phenotypic Battery to Individualize Opioid Use Disorder Treatment for Women Through the Postpartum Period

PROJECT SUMMARY
Opioid overdose is a leading cause of pregnancy-associated mortality with most of these events occurring
through the 12 months after delivery rather than the 9 months before delivery. Historically, the bulk of research
on opioid use disorder (OUD) in this population has focused on pregnancy rather than postpartum. The ‘Fourth
Trimester’ carries significant unique stressors, and women with OUD are especially vulnerable given the addi-
tional stressors they face specific to addiction. Comprehensive treatment during pregnancy includes medica-
tion for OUD (MOUD) with wrap-around services such as behavioral health and prenatal care. However, post-
partum OUD treatment continuation rates are poor, opioid-related deaths increase, and even for women on
MOUD within the month of delivery, postpartum overdose risk is not diminished. We urgently need evidence to
guide how to improve not only postpartum OUD treatment continuation but also its effectiveness at strengthen-
ing recovery, operationalized as abstinence or decreased substance use with improved quality of life. A novel
approach to address this critical knowledge gap is to assess a woman’s multidimensional profile (‘phenotype’)
at the pregnancy to postpartum transition then use that information to tailor her treatment regimen (e.g., dosing
of buprenorphine, addition of other medications, targeted behavioral therapies) going forward after delivery.
Multidimensional (‘phenotypic’) variables that determine one’s profile include biological, neurobehavioral and
psychosocial factors. This strategy is in line with our current understanding of addiction having a neurobiologi-
cal basis modified by one’s psychosocial context that can vary over the lifecourse. The proposed research has
three aims: (1) Obtain qualitative data from women on MOUD and providers in perinatal addiction on chal-
lenges and promoters of recovery specific to the postpartum period, (2) Use this data to systematically revise a
battery developed by NIDA in collaboration with the VCU Institute for Drug and Alcohol Studies to tailor it for
women in the postpartum transition and to be feasible in a busy clinical environment, (3) Assess correlations
between multidimensional variables, treatment and recovery outcomes through 12 months after delivery. The
data from this innovative study will inform a clinical trial of an individualized treatment regimen for postpartum
women on MOUD. This project focuses on two high priority areas to NIDA –personalization of addiction treat-
ments and OUD through the perinatal period. The PI, Dr. Martin, is an Early-Career Investigator, obstetrician-
gynecologist and addiction medicine physician. This career development award will fill gaps in her training nec-
essary for her transition to independence in addictions research (in line with Notice of Special Interest NOT-
DA-20-037). Specifically, Dr. Martin will advance her knowledge and skills in clinical trials, mixed methods re-
search, addiction therapeutics, neurobehavioral science, advanced statistical analyses, professional develop-
ment as well as the responsible and ethical conduct of research. She will work closely with a mentorship team
and consultants with expertise across these specialties to carry out her career objectives and research aims.

Public health relevance
PROJECT NARRATIVE Opioid related deaths have become the leading cause of death among postpartum women through 12 months after delivery; treatment for opioid use disorder with medications and behavioral therapies reduce overdose risk and improve outcomes, but treatment continuation and its effectiveness at strengthening recovery de- creases rapidly after delivery. This career development award will gather patient reported data to guide revi- sions of a pre-existing battery of measures intended to capture an individual’s multidimensional profile at the pregnancy to postpartum transition feasibly in a clinical environment. We will then assess how mechanisms of recovery vary across these profiles through 1 year after delivery in order to inform subsequent clinical trials of individualized treatment regimens for postpartum women with opioid use disorder.